The RaDIANT Health Systems Intervention for Equity in Kidney Transplantation

Abstract
For most patients with end-stage kidney failure, kidney transplantation confers longer survival, better quality of
life, and lower cost, relative to dialysis. Despite these benefits, too few patients make it through the complex
transplant evaluation process, and long-standing racial and socioeconomic inequities exist in access to each
transplant step, including referral, start and completion of the transplant evaluation, and placement on the
waiting list. In 2010, with the explicit goal of improving equity in access to transplant in the US Southeastern
region that includes Georgia, North Carolina, and South Carolina, we created the Southeastern Kidney
Transplant Coalition, a community of transplant stakeholders, including patients, caregivers, medical
professionals, patient advocacy groups, and health system administrators that encompasses all 10 transplant
centers in these states and large dialysis organizations serving a population of >50,000 patients with kidney
failure. Since its inception, our Coalition has conducted several pragmatic interventions of educational and
quality improvement activities at the dialysis facility, provider, and patient levels, finding increased rates of
referral and evaluation start, and reduced racial disparities in these outcomes among Black vs. White patients
and those with lower vs. higher socioeconomic status. Unfortunately, health system barriers persist after
referral and education: more than half of patients referred did not start the transplant evaluation, and 65% of
those referred were never waitlisted. However, prior interventions were limited to interventions at the patient-
and dialysis facility-levels and did not address the structural barriers in the complex process across the health
systems that patients must navigate to get a transplant, including both dialysis facilities and transplant centers.
In surveys of health system staff and a scoping review, we identified persistent health system barriers to
transplant equity, including scheduling logistics, inadequate provider communication across health systems,
and limited transplant provider awareness of inequities. In this proposed RaDIANT Health Systems
intervention, we will leverage proven interventions from our research and use a community-based participatory
research approach to adapt and enhance sustainability of the RaDIANT interventions targeting structural
barriers to evaluation start at the health system level (Aim 1). We will then conduct a hybrid type 1
effectiveness-implementation quasi-experimental study of the RaDIANT Health System intervention among 4
Southeastern transplant centers and ~800 dialysis facilities in GA, NC, and SC with a goal of reducing racial
and socioeconomic inequities in transplant access (Aim 2). Finally, we will conduct a process evaluation
among the participating health systems to assess acceptability, usability, implementation, and sustainability of
interventions (Aim 3). If successful, interventions could be adapted and scaled nationally, where our health
system partners are committed to equity in access to kidney transplantation.

Public health relevance
Narrative Prior successful interventions to address racial and socioeconomic inequities in access to kidney transplantation have been focused on provider- and patient-level interventions, and yet substantial health system barriers have prevented equity in access to kidney transplantation. The proposed study seeks to adapt and enhance sustainability of proven educational and quality improvement interventions to target multiple health systems– dialysis facilities and transplant centers – as well as clinical staff and patients in the Southeastern United States to target the policies, practices, and structures of these health systems that pose barriers to underrepresented minorities with end-stage kidney failure seeking a kidney transplant. If successful, interventions could be adapted and scaled nationally, where our health system partners are committed to transplant equity.